Interleukin 33 Regulation for Cancer Prevention in Chronic Inflammation

Project Summary/Abstract
The overarching goal of the proposed research is to elucidate the initiating mechanisms in the development of
cancer-prone chronic inflammation for cancer prevention and therapy. Chronic inflammatory diseases, such as
chronic dermatitis, pancreatitis, colitis and hepatitis, are major risk factors for cancer. In addition, a tumor-
promoting immune environment, which resembles chronic inflammation, is a key driver of cancer development
across the majority of cancer types. By studying the mediators of the transition from acute to chronic
inflammation, we have demonstrated that interleukin (IL)-33 cytokine is a key initiator of chronic inflammation
that eventually leads to cancer development in the skin, colon and pancreas. Importantly, we have recently
discovered that the nuclear function of IL-33 within the epithelial cells plays an essential role in cancer
development in chronic skin and pancreas inflammation. To develop an effective strategy to suppress cancer-
prone chronic inflammation, we will focus on the mechanism that blocks the initiating steps in the development
of a cancer-prone chronic inflammation. Founded on our innovative discovery that IL-33 is an essential initiator
of cancer-prone chronic inflammation, we aim to determine the mechanism of IL-33 induction in tissues exposed
to inflammatory insults and to develop a novel therapeutic approach to inhibit IL-33 expression for cancer
prevention and therapy. To accomplish this, we will use novel mouse models and clinical samples to (1)
determine the mechanism of IL-33 induction in chronic inflammation triggered by chemical agents, (2) investigate
the role of IL-33 in cancer-prone chronic inflammation associated with a viral infection, and (3) study inhibitor of
IL-33 that can block chronic inflammation and the subsequent cancer development. The outcomes of our
research will establish a fundamental pathway to suppress chronic inflammation-associated cancer and provide
the means to prevent cancer progression and recurrence.

Public health relevance
Project Narrative This proposal is founded on an innovative concept that the inhibition of an immune factor called interleukin 33, which plays a critical role in the initiation of chronic inflammation, can suppress cancer development associated with chronic inflammation. The overarching aim of this proposal is to determine the underlying mechanism that regulates the expression of interleukin 33 in the epithelial cells and to identify inhibitors of its expression. The outcomes of this research will lead to the development of a novel strategy for cancer prevention and treatment, which will benefit a large number of individuals affected by chronic inflammation in the United States and around the world.